Biomarkers and pathogenesis of Alcoholic acute pancreatitis

PROJECT SUMMARY
Acute pancreatitis (AP) affects 270,000 patients/ year in the USA. Alcoholic AP (AAP) is difficult to diagnose due
to under-reporting and lack of a reliable biomarker, with 5-70% of AP being reported as AAP. Alcohol is not a
good biomarker and is detected in only 20% of AAP cases. Phosphatidyl ethanol (PEth), a membrane
phospholipid rapidly formed in the presence of ethanol, is found in blood cells. PEth reflects alcohol intake but
may be unaffected by AAP associated inflammation. However, fatty acids ethyl esters (FAEEs) found in the fat
and pancreas of alcoholics may be excellent AAP biomarkers since FAEEs increase in AAP without detectable
alcohol. Moreover, serum FAEEs >18 nM (normal <10nM) identify covert AAP among those misdiagnosed as
idiopathic AP. Lastly, FAEEs > 2099nM, may predict severe AAP better than the established criteria. Since
human AP universally has visceral fat necrosis, we HYPOTHESIZE that: FAEEs released from fat necrosis
can diagnose AAP, predict its severity, and may worsen the course of AAP. To test this, Aim 1 will validate
FAEEs as biomarkers for AAP. In aim 1A: we will determine the utility of FAEEs as diagnostic biomarkers of
AAP. While NEFA increase only 2-4-fold during AP; the large FAEE increase early in severe AAP may occur in
patients with elevated blood alcohol and predict AAP severity. Thus, aim 1B will study if FAEEs are prognostic
markers for severe AAP. Aim 2 will Determine FAEE’s in relation to alcohol intake, fatty acid composition, AP
etiology and severity. Aim 2A will determine FAEE’s relation to alcohol intake, fatty acid composition in humans
without AP. Our preliminary studies show FAEE concentrations in the fat of alcoholics without AP are ≈1/10th
those of AAP patients. Therefore, Aim 2B will Determine FAEEs in VFN, their relation to AP etiology and NEFA
composition. To understand if FAEEs make AP severe independent of alcohol and fatty acid generation; Aim 2C
will determine the impact of alcohol and FAEEs on AP severity in mice. since alcohol increases NEFA induced
injury in multiple cell types and also FAEE induced organ failure; Aim 3 will determine the mechanisms by which
alcohol increases NEFA and FAEE mediated injury in AAP. Here we will examine the roles of alcohol mediated
aqueous stability of fatty acids (Aim 3A) and PEth generation (Aim 3B) in severe AAP. For this we will use
physical chemistry methods to study whether alcohol increases stability of the normally hydrophobic NEFA or
FAEE monomers, which have long (12-18 carbon) acyl chains. We will also study whether alcohol, or PEth
generation via phospholipase D2 increase an amphipathic interaction between these acyl chains and cell
membrane phospholipids of pancreatic acini, adipocytes and endothelial cells that re injured during AAP. This is
based on a novel interaction responsible for NEFA (and perhaps FAEE) uptake into cells which causes cell
injury. This uptake that can be followed by novel live imaging methods using coumarin tagged NEFA. Overall,
this proposal explores FAEEs as diagnostic and prognostic markers for alcoholic AP and explains how alcohol-
lipid interactions affect the disease course.

Public health relevance
PROJECT NARRATIVE Here we study whether serum fatty acid ethyl esters (FAEEs) may be good biomarkers for diagnosing and predicting the severity of alcoholic pancreatitis. We will also study how alcohol and adipose tissue affect FAEEs, and alcohol or FAEEs in turn affect pancreatitis severity compared to their parent fatty acids.